Extracellular Histones in Burn-induced Microvascular Hyperpermeability

ABSTRACT
Extracellular histones are nuclear proteins released to the extracellular environment during tissue destruction or
injury. Emerging evidence implicates them as danger associated molecules with immunostimulatory capability.
The receptor-signaling mechanisms responsible for their tissue or cell-specific effects are poorly understood. In
recent studies, we detected elevated plasma levels of histones in burn patients as well as animals. Administration
of histones caused microvascular leakage and endothelial hyperpermeability-characteristic pathology underlying
multiple organ dysfunction following burns, whereas histone inhibitors attenuated burn-induced barrier leakage.
Moreover, we obtained novel evidence for the critical role of C-type lectin receptor 2d (Clec2d)-mediated tyrosine
kinase signaling in endothelial response to histones. Built on these intriguing findings, this study will characterize
the release, pathophysiological function, and molecular mechanisms of histones as an important contributor to
burn-induced endothelial barrier injury in edema-prone tissues, including lungs and gut/mesenteric microvessels.
We propose three aims: Aim 1 to characterize circulating histones in burn patients and animals correlated with
organ dysfunction; Aim 2 to determine the causal effects of histones on microvascular hyperpermeability during
burns; Aim 3 to explore the molecular mechanisms by which histones induce endothelial barrier breakdown. The
specific mechanistic hypothesis to be tested is that following thermal destruction of tissues, injured cells release
histones into the circulation where they directly interact with the vascular endothelium by binding to Clec2d and
activating downstream intracellular signaling mediated by Syk/Src-FAK; these tyrosine kinases phosphorylate
proteins that constitute cell-cell junctions and cell-matrix focal adhesions, thereby triggering their conformational
changes and leading to increased permeability. This novel pathway will be tested in innovative experiments that
incorporate newly developed imaging techniques and molecular assays into a comparative analysis of burn
patients, human organs, and animal/cell models. Through this translational study, we expect to gain new insights
that will not only shift the current paradigms in vascular endothelial cell biology, but also fill the gaps of knowledge
in understanding burn pathophysiology. Identification of circulating histones as a key mediator of burn-induced
tissue/organ injury may lead to the development of new diagnostics and therapies for thermal trauma.

Public health relevance
PROJECT NARRATIVE Burns are a common type of trauma that affects approximately 2 million Americans each year. A major cause of mortality in patients with major burns is injured tissue releasing cell death products into the blood to cause small blood vessel leakage. This project investigates the role and mechanisms of increased plasma histones as major cell death products that disrupt blood vessel integrity, with the goal to identify new therapeutics for treating burns.